Assessing the Mycobacterium tuberculosis carriage state

Project Summary
It is hypothesized that Mycobacterium tuberculosis (Mtb), the primary agent of human tuberculosis (TB) has been with the
human population for more than 12,000 years. Although there are nearly 9 million new cases of TB each year, the vast
majority of individuals who come into contact with this organism appear to clear it with no ill effects. The mechanisms
employed during this ‘clearance’ process are generally unknown. In high-exposure TB epidemiologic settings, a small
percentage of contacts go on to develop sputum culture-positive active disease with all symptomology, histopathology and
immune responses that characterize TB; these individuals are assumed to be responsible for the subsequent TB transmission
that occurs. A larger percentage of contacts become tuberculin skin test (TST)-positive but remain culture negative (latent
disease); these individuals likely do not transmit to contacts while in the latent stage. Thus, it is assumed that a majority of
TST-negative individuals have not been exposed to Mtb, or have cleared any bacilli to which they may have been exposed
without inducing immunity. However, these TST-negative contacts rarely have their upper respiratory tracts (URT) cultured
for Mtb.
Major human respiratory bacterial pathogens such as Streptococcus pneumoniae and Haemophilus influenzae utilize an
URT carriage state in which the bacteria attach to the local epithelium, replicate, and transmit to other persons, but do not
damage the host cells, cause disease in this location or induce more than a very mild local inflammation; ultimately, these
commensal bacteria can clear or they can disseminate to sterile areas of the body including the lower lung and brain and
cause disease. Infant humans are URT colonized at higher rates than adults with correspondingly higher rates of meningitis.
Importantly, some vaccines can clear URT colonizing bacteria and thus prevent subsequent disseminated disease states or
transmission to naïve contacts. Data from TB studies not originally designed to assess carriage have indirectly demonstrated
that Mtb also possesses a URT carriage-like state in humans (and we have demonstrated it in natural transmission studies
in ferrets), and if similar to the other respiratory pathogens, understanding this state is critical to ultimately more accurately
diagnosing, controlling disease development and transmission and improving vaccine efficacy. We intend to perform a
longer-term Mtb URT carriage analyses in asymptomatic adult humans in Kampala, Uganda exposed to active TB cases.
Investigators in the field consider Mtb carriage to either not exist, or not be relevant in the case of transmission and
development of disease. Preliminary evidence indicates this is not the case. If accurate, this may be a significant missing
component in our efforts towards developing a comprehensive control strategy for TB.

Public health relevance
Project Narrative Understanding and interfering with person-to-person transmission is the most basic component needed for successful control of disease spread within populations with pathogens such as Mycobacterium tuberculosis (Mtb), the primary causative agent of human tuberculosis. All respiratory bacterial pathogens thus far examined can cause serious disease, but also utilize an asymptomatic upper respiratory tract (URT) carriage state in which the bacteria attach to surface epithelial cells, slowly replicate, and transmit to other persons, but do not cause damage, disease, or induce more than a very mild local inflammation in the host. Many investigators in the field consider Mtb carriage nonexistent, or not relevant; however, studies by investigators assessing aspects of human disease development and by our group studying ferret transmission have indirectly demonstrated that Mtb may also possesses a URT carriage-like state, and if similar to the other respiratory pathogens, confirming and better understanding this state could significantly aid efforts towards better understanding Mtb transmission and ultimately better tuberculosis control.